The Breast Cancer and the Workforce Communication App: A randomized controlled trial of an English/Spanish intervention to promote long-term job retention

ABSTRACT
Of the many stressors associated with a breast cancer diagnosis, job loss is one of the most impactful yet
understudied. Long-term financial consequences can include difficulty paying bills, accumulation of debt, and
bankruptcy. Importantly, bankruptcy in cancer survivors has been linked to decreased treatment adherence
and increased mortality. Women with access to work accommodations, such as schedule flexibility, are more
likely to work during chemotherapy and to retain their jobs in the long term. Similarly, women with adequate
sick leave may choose to take time off while maintaining job security. However, low-income minorities are less
likely to have such accommodations, leading to higher rates of job loss and financial distress. For these
patients, finding a way to continue to work during treatment is critical. In the Breast Cancer and the Workforce
study, which focuses on immigrant and minority women, symptom burden and lack of work accommodations
were both linked to job loss. Only 57% of pre-diagnosis employed low-income women retained their jobs after
treatment completion, compared to 93% of higher-income women. Of those not working, 84% attributed their
lack of employment to cancer symptoms or treatment. Low-income women were less than half as likely as
higher-income women to have accommodating employers and only one-fourth as likely to retain their jobs.
However, patients whose confidence in asking for work accommodations improved over time were more than
five times as likely to retain their jobs than those whose confidence did not improve. There is a compelling
need for an effective intervention to support working during treatment in low-income immigrant and minority
breast cancer patients in order to improve long-term job retention and financial stability. The goal of the
proposed study is to evaluate the effectiveness of a mobile application (app) developed to promote working
during adjuvant (curative) breast cancer chemotherapy. The app has a two-pronged approach: it will help
women communicate with clinicians to optimize symptom control, and it will help them communicate with
employers to negotiate for accommodations. Our study is grounded in evidence that communication behaviors
can be taught to patients of varying English proficiency, resulting in improved responsiveness to patients'
needs. Furthermore, patient-physician communication strategies can be adapted for use in the work setting.
Our app applies these principles to the workplace as well as the clinic. The use of an app to deliver the
intervention is appealing in light of barriers our target population faces in accessing support and the high
prevalence of smartphone use. We will randomly assign English- and Spanish-speaking women who are about
to undergo chemotherapy for stage I-III breast cancer to receive the app or an informational booklet (control).
Participants will complete surveys at baseline and during chemotherapy to assess symptom burden and work
accommodations. Surveys 4 months and 1 and 2 years post-treatment will measure long-term job retention.

Public health relevance
PROJECT NARRATIVE Low-income immigrants and minorities have limited access to workplace accommodations, such as a flexible schedule, which allow women undergoing curative chemotherapy for breast cancer to work during the treatment period and retain their jobs in the long term. As a result, they are at increased risk of job loss and its financial consequences, including difficulty paying bills, depletion of savings, accumulation of debt, and bankruptcy. Importantly, job loss and bankruptcy have been linked to decreased treatment adherence and increased mortality in cancer survivors. Our study will test the effectiveness of a mobile health application designed to support working during the treatment period by increasing access to accommodations and optimizing symptom control, with the ultimate goal of promoting long-term job retention and financial stability.